CB1 Allosteric Modulators: Molecular, Cellular and In Vivo Pharmacology

PROJECT SUMMARY Please see Research Strategy section.

Public health relevance
NARRATIVE The Project Narrative is not a required section for the Administrative Supplements to Existing NIH Grants and Cooperative Agreements (PA-18-591).